PITUITARY FUNCTION DURING CHRONIC LEUPROLIDE ACETATE ADMINISTRATION

This research seeks to further clarify pituitary function during chronic leuprolide acetate administration to determine pituitary suppression in subjects utilizing 7.5 vs. 375 mg. Lupron R.